IMPRINT Confined Spaces

Project Summary/Abstract
Workers are exposed to hazards in confined spaces at Superfund sites and waste treatment plants and
during emergency or disaster response in ever increasingly complex scenarios due to climate change related
challenges like infectious disease, heat, and flooding. There is a need for short, incident-specific awareness
training that can be delivered using technology-enhanced training products to support the health and safety of
workers exposed to known, emerging, and new hazards from climate change. Existing field training exercises
(FTX) for confined spaces provide live operational readiness preparation to perform basic entry and rescue in a
standard set of scenarios; however, they are limited in their ability to address the full range of health and safety
threats facing workers. Therefore, emergency response training organizations need a cost-effective training
solution that increases the stakes and authenticity of simulations to better equip trainees to remain safe and
effective when they are in the field.
We will extend Charles River’s existing hazardous material (HAZMAT) and hazardous waste operations and
emergency response (HAZWOPER) training tool—developed with support from the National Institute
Environmental Health Science Worker Trainer Program (NIEHS WTP) and our partnership with The New
England Consortium—to design Immersive Modular Preparedness Tutor for Confined Spaces Training
(IMPRINT Confined Spaces). IMPRINT Confined Spaces uses narrative case study adaptive training with a
mixed reality experience that combines physical and virtual environments to increase the stakes, authenticity,
and training scenarios available to training organizations. We will extend IMPRINT’s capabilities through the
development of an intelligent tutoring system tailored to the needs of adult learners, providing a strong theoretical
basis to our training system’s continued development.

Public health relevance
Project Narrative In IMPRINT Confined Spaces, Charles River Analytics will provide a portable, immersive, and intelligent mixed reality (MR) training system to support existing training organizations and consortia as they adapt to evolving challenges due to climate change. Results from this Phase I effort will include a prototype system that will complement existing training and be evaluated for skill transfer under a follow-on Phase II effort. IMPRINT Confined Spaces will enable instructors to provide engaging, realistic, and adaptive intelligent virtual training, improving worker health and safety.